Novel, bio-inspired chloramine for infection eradication in chronic wounds

PROJECT SUMMARY
Topical antiseptics are a key strategy in the treatment of infected diabetic foot ulcers (DFUs) to enhance the
opportunity to rehabilitate and heal. DFUs can result in osteomyelitis of the foot and amputation of lower
extremities. Halomine, doing business as AvantGuard, has developed Avantamine, a stabilized chlorine
containing chloramine, that creates a novel active with residual efficacy to compete in the antiseptic space,
providing excellent broad-spectrum efficacy and no history of resistance generation. Chlorine is naturally
biocompatible biocide compared to alternative chemistries because our bodies already utilize chlorine:
neutrophils take chlorine from salt in bodily fluids to produce hypochlorous acid (HOCl) as an intermediary before
ultimately generating taurine chloramine. Given the biocompatible nature and naturally skin-compatible pH
compared to Dakins solution, HOCl has recently become popular generally at 0.033% or less concentration for
wound cleaning, but HOCl is limited by stability preventing general use at concentrations that would be most
effective.
Avantamine is a combination of an n-halamine containing monomer and other monomers that improve solubility
in water. Key differentiators are: Avantamine is broad spectrum; the molecules are too large for cellular uptake,
reducing systemic toxicology risk; no resistance generation; the formulation has shown no skin irritability; chlorine
is a quick and efficient antimicrobial.
The proposal is designed to optimize the product against bacteria found in DFUs to decrease the persistence of
the chronic wounds. To this we will: 1) examine efficacy against bacteria using a porcine tissue skin model to
understand the performance with a milestone of a 3-4 log reduction in CFU; and 2) evaluate in an in vivo porcine
model, which is the most similar to humans for skin behavior. The goal is to show improved efficacy over the
currently most effective antiseptics.

Public health relevance
PROJECT NARRATIVE Halomine, doing business as AvantGuard, is developing a stabilized chlorine containing chloramine compound as an effective antibacterial focused on skin infections, with no known resistance, to reduce, prevent, and eradicate bacterial infections. The product is a topical skin treatment oriented to treat biofilms in diabetic foot ulcers.